Regulation of phase separation in neuronal heterochromatin

ABSTRACT
One of the most astonishing feats in all of biology is the process by which chromatin, the complex of DNA,
histone proteins and associated factors, becomes compacted from a length of 2 m into nuclei that measure just
microns across. Unsurprisingly, our understanding of the principles that govern this process is in its infancy. My
lab became interested in this process after we identified the Ferguson-Bonni ANAPC7 neurodevelopmental
syndrome caused by mutation of the degradative ubiquitin ligase Anaphase-Promoting Complex (APC). We
discovered that Ki-67 was the major APC7-dependent target in post-mitotic neurons, where it accumulated in
constitutive heterochromatin. Subsequent experiments in complementary mouse mutants demonstrated a much
broader role for the APC in regulating the composition of neuronal heterochromatin, where we also observed
dramatic accumulation of the chromosome passenger complex (CPC) and its product phosphorylated histone 3
(H3S10ph). Like Ki-67, the contributions of the CPC and H3S10ph to neurologic disease had been previously
unknown. Although these observations established an APC-dependent ubiquitination-phosphoprotein axis in
neurodevelopmental chromatin regulation, how Ki-67 and H3S10ph control heterochromatin remained poorly
defined. We hypothesize that Ki-67 and H3S10ph control liquid-liquid phase separation (LLPS), a
physicochemical process driven by multivalent interactions of disordered proteins like Ki-67 and phosphoproteins
like H3S10ph. Studies from other labs showed that LLPS of constitutive heterochromatin requires the small
protein HP1α, which interacts with Ki-67. Data from my lab showed that neuronal Ki-67 undergoes rapid
relocalization away from heterochromatin upon disruption of LLPS, indicating Ki-67’s association with constitutive
heterochromatin requires LLPS. This compelling series of observations leads us to the central hypothesis of this
proposal: LLPS of heterochromatin-associated APC targets is required for neurodevelopment and when
perturbed contributes to the pathogenesis of APC-related neurodevelopmental disorders. In Aim 1, we will
explore the role of Ki-67 in the formation of heterochromatin in neurons using imaging and molecular analyses
of a novel mouse model of Ki-67 mutation. In Aim 2, we will employ elegant in vitro assays to determine how Ki-
67 enhances LLPS of HP1α and nucleosome arrays. In Aim 3, we will explore the liquid-like behavior of APC
substrates Ki-67 and the CPC by imaging heterochromatin dynamics in live neurons. Armed with novel in vivo
genetic systems, powerful in vitro assays, and world-class expertise in the wet lab and computational methods,
we are poised to generate fundamental insight into chromatin regulation by ubiquitin and LLPS in neurons.

Public health relevance
PROJECT NARRATIVE The primary objective of this project is to determine how the formation of heterochromatin is driven by targets of the degradative ubiquitin ligase anaphase-promoting complex (APC), including Ki-67 and phosphorylated histone 3. The elegant experiments we propose aim to test the hypothesis that these APC-targets drive heterochromatin formation by promoting the biophysical process of phase separation. Achieving these aims will provide fundamental insight into the role of chromatin regulation in neurons and the contribution of this process to inherited disorders of neurodevelopment.